Physiologic and Genetic Contributions of Impaired Fetal Brain Development in Congenital Heart Disease

PROJECT SUMMARY
Congenital heart disease (CHD) is the most common birth defect and, as survival has improved for patients with
moderate-severe CHD, adults now outnumber children with this diagnosis. This reduction in mortality has shifted
research focus to improving long-term outcomes and quality of life. The most common adverse outcome is
neurodevelopmental impairment and occurs in 50% of patients with moderate-severe CHD. While postnatally
measured medical and surgical factors play a crucial role in the care and outcomes of these infants, brain
magnetic resonance imaging (MRI) studies have identified impaired brain development even before cardiac
surgery and have emphasized the fetal period as a time when these abnormalities are evolving. These data
suggest fetal interventions may be an important aspect of improving the high rates of neurodevelopmental
impairments in CHD. The National Heart, Lung, and Blood Institute has highlighted a need for research focused
on preventive and therapeutic strategies for reducing neurodevelopmental deficits in CHD. This Mentored
Patient-Oriented Career Development Award aligns well with this need by aiming to characterize the trajectory
of disrupted cortical brain development in fetuses with moderate-severe CHD and to understand mechanistic
interactions between physiologic and genetic variation that underlie brain disruption in this population. These
data will assist in identifying the timing and population of CHD fetuses that may benefit from fetal neuroprotective
interventions and will inform risk prediction for patient counseling.
This Award will provide the candidate the education, training, and mentoring necessary to successfully undertake
this proposal and to develop the skills required to become an independent clinician scientist focused on improving
neurodevelopmental outcomes in patients with CHD. Dr. Ortinau has already developed expertise in MR analysis
techniques. Thus, the training and mentorship for this award will focus on: 1) enhancing knowledge of fetal
cardiac physiology and developing expertise in the association of cardiac physiology with cerebral
hemodynamics and fetal brain development; and 2) gaining knowledge and experience in genetic and genomic
research to understand the contribution of genetic variation to cerebral cortical development. The unique
environment at Washington University School of Medicine provides the opportunity to train in these key areas
using the infrastructure, resources, and mentorship outlined in the candidate’s Career Development Plan. These
research activities will provide the preliminary data necessary for development of an hypothesis-driven R01
application in Year 2 of this Award, aimed at understanding mechanistic interactions between physiologic and
genetic pathways that may underlie disruption of brain development in moderate-severe CHD.

Public health relevance
PROJECT NARRATIVE This proposal aims to investigate the pattern and trajectory of cerebral cortical development in fetuses with congenital heart disease and establish the impact of altered cerebral hemodynamics and genetic variation on fetal brain development. This proposal will help establish a valuable platform for future studies focused on the mechanistic interactions between cerebral hemodynamics, genetic variation, and fetal brain development. These data may also assist in the development of neuroprotective strategies and design of future studies linking fetal imaging with later imaging and neurodevelopmental outcomes.